Reducing Psychological Distress in Fire Fighters with an Asynchronous App-based Meditation Intervention

ABSTRACT
More than one million firefighters in the United States provide critical emergency medical services in
communities they serve and have been on the front lines of healthcare delivery, including throughout the
COVID-19 pandemic. As a result of exposure to occupational stressors, a high proportion of firefighters
experience considerable stress-related illness burden, including chronic pain, psychological distress (i.e.,
anxiety and depression), and posttraumatic stress disorder. Although interventions have been developed to
address this high need of reducing effects of occupational stress exposure in order to improve firefighter well-
being (e.g., cognitive-behavioral therapy, resilience training), not all of these modalities appeal to all
firefighters, nor are they easily implemented without direct, in-person contact. One modality that has shown
promise to reduce distress in various populations is meditation, including meditation delivered by smartphone
apps. To the best of our knowledge, no smartphone-based meditation interventions designed to cultivate both
mindfulness and feelings of social connection to others have been tested with firefighters. This study will
therefore test the efficacy of a 10-day, smartphone-based meditation app intervention among N=192 career
firefighters. The app was developed by Health Minds Innovations (HMI, Madison, WI) and is designed to
enhance both mindfulness (awareness) and social connection to others in order to reduce anxiety. Our group
recently piloted tested this app and found that firefighters exhibited reduced anxiety (a key component of
psychological distress) and burnout, as well as improved function of the stress hormone, cortisol, from before
to after use of the app. Although these encouraging results suggest a low-cost, scalable smartphone-based
meditation app may be effective to improve firefighter well-being, our pilot study lacked an attention control
comparison needed to establish intervention efficacy. Therefore, in collaboration with 3 metropolitan fire
departments in the United States, we will test the efficacy of the HMI meditation app to reduce psychological
distress compared to a rigorous active attention control (i.e., a Health Education app, based on our prior
work)(Aim 1). We will also determine whether the effect of the HMI meditation app of psychological
distress is mediated by mindfulness and perceived social connection (Aim 2). The proposed research will
provide important evidence of efficacy about a smartphone-based meditation app intervention, with likely
high impact, that cultivates both mindfulness and social connection in order to reduce psychological
distress in frontline workers in the fire service. This research supports NIOSH's Strategic Goal 7 / Activity
Goal 7.14.1 (to develop interventions that integrate protection from work-related health hazards with
promotion of prevention to advance worker well-being) and NORA Objective 6 (promote healthy work
design and well-being).

Public health relevance
The more than one million firefighters in the United States provide critical emergency medical services in communities they serve and are on the front lines of healthcare delivery, including in the post-pandemic world. As a result of exposure to occupational stressors, a high proportion of firefighters experience considerable stress-related burden including psychological distress (i.e., anxiety and depression). To address this need, this project will test the efficacy of an app-based meditation intervention to improve well-being among career firefighters.